Pilot & Feasibility Core

PILOT AND FEASIBILITY PROGRAM: PROJECT SUMMARY
The Center for American Indian and Alaska Native Diabetes Translation Research (CAIANDTR) nurtures
innovative research at the intersection of diabetes, related morbidities, and health inequities, focusing on their
prevention, treatment, and consequences across the lifespan. It funds Early Stage Investigators to conduct
secondary analyses that can answer important questions about diabetes and related conditions in American
Indian and Alaska Native (AI/AN) populations. Such investments seed emerging research areas and
facilitate development of promising investigators, thus helping to enhance scientific knowledge
related to diabetes in Native communities and to expand the workforce that can move diabetes translation
research in this population forward. CAIANDTR's Pilot and Feasibility Program will support at least two pilot
projects during each project year. Projects will last 18 months, with the first 12 months focusing on completion
and publication of a proposed secondary analysis and the final six months aimed at development of a grant
application (e.g., R21, K01). Throughout each project, awardees will receive formal training (e.g., scientific
writing, grant development) and regular mentorship. Projects will be reviewed monthly for progress and
resources will be provided to address barriers to investigator success. The Annual P&FP Awardee Meeting
represents an opportunity for networking and scientific exchange as well as collection of evaluation data to
enable continuous improvement of the P&FP.